Research Capacity Core

PROJECT SUMMARY
The mission of Tuskegee University (TU) RCMI Research Capacity Core (TU RCC), also
referred to as the Research Infrastructure Core (TU RIC), is to establish and sustain a
supportive environment for biomedical research at TU, including reliable and state-of-the-art
physical resources. These services, shared facilities, and equipment managed by the TU RCC
provide the opportunity for the TU faculty to utilize, efficiently and synergistically, available
resources and to collaborate internally and externally. TU, an HBCU, is an RCMI institution that
receives funding from the NIH for the purposes of increasing the proportion of minority
researchers in biomedicine and to increase studies in minority health.